Characterization of the Staphylococcus aureus fatty acid degradation pathway

PROJECT SUMMARY/ABSTRACT
Bacteria require fatty acids for a variety of biological functions, including the construction of phospholipids.
Staphylococcus aureus, like other bacteria, synthesize fatty acids using a fatty acid biosynthesis pathway
referred to as FASII, but can also scavenge fatty acids from the environment using the recently described fatty
acid kinase (Fak) pathway. In addition to fatty acid biosynthesis and acquisition, it is common for bacteria to
degrade fatty acids using fatty acid degradation (Fad) enzymes. Bacteria can degrade fatty acids for energy
production (known as b-oxidation) but can also degrade fatty acids to alter the length of the acyl chain. S. aureus
has been thought to not possess the capacity to degrade or perform b-oxidation of fatty acids. This is due, in
part, to the absence of a key crotonase enzyme. This is surprising considering that S. aureus is annotated to
encode all the other necessary Fad enzymes, though their function has not been confirmed. During RNAseq
studies of the Fak pathway, we observed an ~17-fold increased expression of the group of genes annotated to
encode Fad proteins when the Fak pathway was inactivated. Indeed, no crotonase enzyme was apparent,
though all the other Fad functionalities were annotated. Using bioinformatics, we identified a putative crotonase
enzyme in S. aureus that we now call FadB based on nomenclature in other systems. When co-expressed with
S. aureus FadA, FadB can functionally complement an E. coli fadA and fadB mutants on minimal media with
fatty acid as a sole carbon source. This demonstrates that 1) S. aureus FadB can substitute for the E. coli
crotonase activity-containing enzyme, and 2) S. aureus does possess a complete Fad pathway and likely can
degrade fatty acids. We seek to characterize the regulation of this pathway, demonstrate the saFadA and saFadB
proteins form a complex like the E. coli proteins, and demonstrate the functionality of the S. aureus Fad pathway
in three Specific Aims.
Aim 1 will identify regulatory proteins of the Fad operon. Aim 2 determines if the S. aureus FadA and FadB
proteins form a complex. In addition, Aim 3 examines the ability for S. aureus to degrade fatty acids and use
them as alternative carbon sources using controlled expression of the Fad genes using a combination of 13C-
labeled fatty acids with mass spectrometry and growth assays.
The Fad-encoding genes have been identified in a variety of transcriptomic studies but have remained
unstudied. This is likely due to the known dogma in the field that S. aureus does not possess a complete Fad
pathway and cannot degrade fatty acids. We anticipate that the completion of this application will redefine fatty
acid metabolism in S. aureus and determine for the first time that S. aureus can degrade fatty acids. This will
change how the field understands S. aureus metabolism and will set the stage for future applications examining
the role of this pathway in cell physiology and pathogenesis.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is an extremely successful bacteria at causing human diseases. In this study, we examine the ability of methicillin resistant Staphylococcus aureus (MRSA) to degrade fatty acids. These studies will help understand better the metabolic capabilities of this important bacterium.